Leveraging the E3 Ligase RNF166 to Prevent T Cell Exhaustion in Solid Tumors

PROJECT SUMMARY
Adoptive T-cell therapies (ACT) have emerged as a transformative approach in cancer immunotherapy,
demonstrating remarkable success in hematological malignancies. However, their application in solid tumors is
significantly limited by T-cell exhaustion (TEX), a dysfunctional state driven by chronic antigen stimulation and
exacerbated by the environmental stresses of the tumor microenvironment (TME). TEX is marked by impaired
proliferation, diminished effector function, and the upregulation of inhibitory receptors, ultimately curtailing the
therapeutic potential of ACT. To overcome this barrier, innovative strategies are needed to engineer T-cells
capable of maintaining their function and persistence within the challenging TME. E3 ubiquitin ligases (E3s) are
critical regulators of protein stability and cellular adaptation under stress, yet their roles in TEX remain largely
underexplored. Preliminary proteomic studies revealed significant global changes in protein turnover during TEX
including the destabilization and loss of the T-cell receptor (TCR) complex, stabilization of inhibitory receptors,
and the destabilization of costimulatory receptors. This discrepancy is partially attributed to the accumulation of
unfolded proteins and the resulting compensatory increase in proteasomal activity. Through additional proteomic
analysis modeling of TEX, I have revealed multiple E3s important to T-cell function. To determine which E3 has
the greatest impact on T-cell function, I conducted an overexpression screen of multiple E3s in primary murine
tumor-specific CD8+ T-cells. T-cells overexpressing each E3 were evaluated using serial in vitro cytotoxicity
assays to assess their ability to control cancer growth. I identified the E3 ubiquitin ligase Ring Finger Protein 166
(RNF166) to enhance T-cell persistence, prolonging the cytotoxic function of the T-cells by 8 days. Further,
elevated transcript levels of RNF166 in tumor infiltrating lymphocytes was found to correlate with responsiveness
to immune checkpoint blockade (ICB) in metastatic melanoma. Additionally, I demonstrate that RNF166
overexpression reduces the expression of inhibitory receptors PD1, CTLA4, and LAG3 following chronic
stimulation in primary human CD8+ T-cells. This proposal aims to elucidate the mechanisms by which RNF166
regulates T-cell function and explore its therapeutic potential to enhance ACT for solid tumors. Aim 1 will define
the molecular targets of RNF166 using innovative proteomics approaches to investigate its impact on global
proteome turnover and determine its targets for proteasomal degradation. Aim 2 will evaluate the efficacy of
RNF166 overexpression in enhancing ACT using preclinical models, including murine syngeneic OT-1 T-cell and
human CAR T-cell systems. This research represents the first comprehensive study of RNF166 in T-cell biology,
providing critical insights into its role in TEX and its potential as a therapeutic target. By leveraging state-of-the-
art mass spectrometry, bioinformatics, and in vivo modeling, this work aims to develop novel immunotherapeutic
strategies to enhance ACT for solid tumors. This research proposal represents a unique training opportunity
combining high-level mass spectrometry training, bioinformatics, systems biology, and cell engineering.

Public health relevance
NARRATIVE Adoptive T-cell therapies (ACT) hold immense promise in cancer immunotherapy, yet their efficacy in solid tumors is hindered by T-cell exhaustion (TEX), a dysfunctional state driven by chronic antigen stimulation and environmental stress within the tumor microenvironment. Preliminary studies have identified RNF166, an E3 ubiquitin ligase, as a critical regulator of proteome stability in T-cells, with overexpression of RNF166 enhancing T-cell persistence and tumor-killing capacity. This innovative research aims to define the molecular targets of RNF166 and evaluate its potential to prevent TEX and control solid tumor growth in vivo, offering a novel therapeutic strategy to improve ACT for solid tumors.